CREATE Methods Core

Project Summary. The Center for Responsible and Equitable AI Technology Evolution for Mental Health
(CREATE) Methods Core will make important contributions to support the scalable implementation and delivery
of evidence-based psychotherapies (EBPs) for PTSD using Large Language Models (LLMs). The overarching
goal of the Methods Core is to serve the Center through 1) shared technical infrastructure and centralized
expertise for the Development and refinement of Mental health Adaptive Guidance and Interactive
Conversational (MAGIC) tools; 2) Incorporating implementation considerations at the earliest stages of
intervention design; 3) Design of rigorous yet flexible research and evaluation methodologies; 4) Developing
and testing LLM-based strategies to activate and assess mechanisms of change. Three exploratory projects
and a signature project will be supported by the Methods Core LLM development team comprising clinical
psychologists, PTSD experts, experts in culturally appropriate EBP delivery for trauma, computer scientists
and specialists in AI and human-computer interaction, a health economist, implementation scientists, health
service researchers who have implemented PTSD treatments with under-represented clinical populations, a
biostatistician, and experts in ethics and digital mental health. We plan to develop best practices and novel
strategies for an inclusive, end-user involved development approach based on the Discover, Design, Build,
Test (DDBT) framework. We will meaningfully involve administrators, therapists, and patients in the design and
build process including opportunities for end-users to refine and test LLMs. Based on our findings and
innovations, we will develop materials and resources to support inclusive, equitable, and culturally responsive
development and testing of future LLM-based tools, including support for a broader range of EBPs. We will
apply and refine a comprehensive Readiness Evaluation for AI Deployment and Implementation (READI)
framework to evaluate each CREATE MAGIC tool (including pilot projects) for Safety, Privacy Equity,
Effectiveness, Engagement, and Readiness for implementation. Cross-project evaluations will allow us to
examine user experience and perspectives, implementation determinants, costs, and feasibility of integration of
MAGIC tools into existing workflows. We will provide tools and methodologies to support broader use of the
READI framework. Additionally, across projects, we will develop a cutting-edge, LLM-based approach to
identify whether key mechanisms of change (such as active learning, cognitive change, behavioral intention,
and improved skills) are activated by interaction with the MAGIC tools that we develop and test. CREATE will
partner with EBP training programs and mental health systems to test these tools in routine care settings in
three exploratory projects and a signature project.

Public health relevance
The Center for Responsible and Effective AI Technology Enhancement (CREATE) of Treatments for PTSD Methods Core (MC) will make important contributions to support the use of effective treatments for PTSD using Large Language Models (LLMs). The overarching goal of the Methods Core is to serve the Center through Development and refinement of LLM-based tools that are designed to integrate into routine treatment settings and testing their effectiveness and readiness for deployment. To support this work across center research projects our team will involve people who will ultimately be using these tools in every stage of the design process, and evaluate the Safety, Privacy, Fit, Effectiveness, Engagement and Readiness for implementation of each tool.